Consortium for Viral Systems Biology (CViSB)

SUMMARY
The Center for Viral Systems Biology (CViSB) proposes to host the 2024 Annual Meeting of
the Systems Biology for Infectious Diseases Consortium on September 25th and 26th in
San Diego, California. The National Institutes of Health (NIH) U19 funding mechanism
provides substantial scientiﬁc or program staﬀ assistance, guidance, coordination, and
participation in project activities. This includes facilitating collaborations and leveraging
resources available to the Program. The annual Systems Biology meeting exempliﬁes these
goals by fostering collaboration among Centers and maximizing consortium resources.
However, the primary focus of annual meetings remains reporting research progress,
identifying new research directions, and updating NIAID on critical needs.
As the host of the 2024 annual meeting, CViSB will organize the two-day event to (1)
encourage participation by Systems Biology in Infectious Diseases Research Center
members, NIAID Program staﬀ, and Scientiﬁc Advisory Group members, (2) showcase
Center research, (3) provide professional development opportunities and (4) promote
discussion and collaboration.

Public health relevance
PROJECT NARRATIVE The Center for Viral Systems Biology (CViSB) proposes to host the 2024 annual meeting in San Diego on September 25th and 26th, 2024. The goal of the annual meeting is to report progress, seek new research directions and ideas, and update NIAID on issues of need. The speciﬁc aim of the supplement is to provide the event space, and resources needed to accomplish these goals.